The Kansas Department of Agriculture's Maintenance of Human and Animal Food Rapid Response Team

Project Summary
Summary of Proposed Activity
The Kansas Department of Agriculture (KDA) will collaborate with Kansas Department of Health and
Environment (KDHE) and FDA to continue maintenance of a Human and Animal Food Rapid Response
Team for all scales of food and feed emergencies. The Kansas RRT will have the combined expertise and
resources of subject matter experts across multiple agencies and departments, leading to a
multidisciplinary approach that facilitates a coordinated, efficient, and effective response. The RRT
cooperative agreement will allow the Kansas RRT to efficiently maintain the progress it has made in
efficiently responding to food-related emergencies long-term. The mission of the Kansas RRT is to
effectively respond to foodborne outbreaks and identify potential preventative practices to protect the
food supply and consumer health nationally and globally as part of a fully integrated food safety system.
Statement of Objectives, Long-Term Goals, and Methods to be Employed
The Kansas RRT is made up of core members from the Kansas Department of Agriculture Divisions of
Food Safety & Lodging and Dairy & Feed Safety, Kansas Department of Agriculture Emergency
Management, Kansas Department of Agriculture Laboratory, Kansas Department of Health and
Environment Bureau of Epidemiology and Public Health Informatics (KDHE Epi), and FDA.
Representatives from the Kansas RRT will meet bi-weekly with FDA partners from the HAF-2W division
to discuss updates, progress, and obstacles the team is facing. The Kansas RRT will work on a day-to-day
capacity to coordinate with KDHE Epi to receive and respond to foodborne illness outbreak complaints
with action and education. As other food- or feed-related emergencies arise, the RRT has the expertise
and capacity to stand up an Incident Management Team with a Unified Command structure to respond
to disasters. The Kansas RRT will develop a steering committee that will meet internally on a to-be-
determined frequency to discuss resource needs for RRT maintenance, RRT training plans, and stay
abreast of pressing updates relevant to the team. In total, the Kansas RRT will operate with the goal of
protecting public health in mind by implementing strategies of continuous improvement to maintaining
and enhancing a robust all-hazards food and feed protection program in collaboration with state and
FDA partners.

Public health relevance
Kansas Human and Animal Food Rapid Response Team Project Narrative The Kansas RRT will enter the maintenance phase of developing an all-hazards food and feed protection program in collaboration with other state RRT and FDA partners. The mission of the Kansas RRT is to effectively respond to foodborne outbreaks and identify potential preventative practices to protect the food supply and consumer health nationally and globally.